Role of IPMK in generation of small intestinal carcinoid

Serotonin secreting small intestinal neuroendocrine tumors (SI-NET) are primary malignancies of the
small bowel. When clinically recognized, afflicted patients often present with advanced disease and a
poor 5-year prognosis (~36%). Surgery is the most common treatment of SI-NET. The genetic basis of
Familial SI-NET is distinct from sporadic SI-NET. The only reported mutation linked to familial SI-NET is
four base pair deletion mutations in the IPMK (Inositol polyphosphate multikinase) gene. IPMK protein is
416 amino acids in length,and the mutation truncates it to 333, eliminating the C-terminal ATP binding site
and partial nuclear localization signal. IPMK heterozygous mutation exhibits a reduction of its kinase
activity and nuclear localization. IPMK is the rate-limiting enzyme in the higher-order inositol synthesis
pathway and generates inositol penta-phosphate. In mammalian cells, IPMK also acts as a PI3kinase.
IPMK is primarily enriched in the nucleus, and loss of function of IPMK impairs p53 mediated
transcription. As loss of p53 function is highly linked to several intestinal cancers, we like to investigate
the importance of IPMK mutant (found in SI-NET patients) in p53 mediated apoptosis or cell cycle arrest
in the origination of malignancies and tumor formation. How, homozygous loss of function of IPMK and a
heterozygous mutant form of IPMK impair p53 mediated apoptosis and cell cycle arrest is entirely
unknown and worth investigating to understand the molecular mechanism of SI-NET origination. Using
Cre-Lox technology, we developed an intestinal epithelial cell-specific IPMK conditional homo and
heterozygous KO mouse to understand the mechanism of IPMK mediated SI-NET development. We
propose three specific aims—Aim 1. Determine how IPMK gene dosage affects the extent of SI-NET in
mice. The histo-pathological, immuno-histochemical, and biochemical analysis will be performed to
understand how hetero and homozygous loss of IPMK affects intestinal homeostasis and the extent of
SI-NET generation in an age dependent manner. Aim 2. To determine if IPMK is necessary and sufficient
to enhance cell proliferation and cell cycle regulation. Cell biological and flow-cytometric analysis will be
performed to understand the critical function of IPMK in regulating cell proliferation and apoptosis. Aim 3.
Determine if p53 is necessary for IPMK signaling-induced apoptosis and cell cycle arrest.